Development of a practical quantitative non-contrast approach for cerebrovascular MRI

Multi-contrast MRI sequences before and after gadolinium enhancement of the carotid
plaque can significantly improve determination of stroke risk compared with simple
carotid stenosis measurements. While the improved depiction of plaque features with
MRI can be used to better individualize therapy for veterans with carotid disease, its use
has been limited because it requires gadolinium-based contrast agents, extended exam
times, and extensive interpretive training. To address these remaining limitations and
move our field forward into clinical application, our multicenter team of investigators will
combine our extensive collective experience in carotid MRI to develop a novel rapid non-
contrast quantitative carotid imaging method to automatically and accurately identify
vulnerable plaque components. Our goal is to establish a method for accurate carotid
plaque mapping that can be obtained with 1 to 3 MRI sequences taking ≤10 minutes for
the total plaque exam. To accomplish this goal, we will consolidate our different
quantitative carotid MRI sequences into two different methods of measuring these
quantitative parameters (NEW1 and NEW2). We will then compare these two methods
against each other and against the conventional multi-sequence contrast enhanced
carotid MRI method (CONV) in a study of 100 veterans with carotid disease at our 5
VAMC’s. Scans from repeat visits will be used to test repeatability of the parametric
measurements and will be performed with high-performance neck-shape-specific (NSS)
carotid coils. Our hypothesis is that vulnerable carotid plaque components (intraplaque
hemorrhage, lipid rich necrotic core, calcification, total plaque volume, and thin or
ruptured fibrous cap) can be accurately identified using rapidly acquired quantitative MRI
parameters (relaxation times, diffusion coefficient, and proton density signal intensity).
Specifically, that NEW1 or NEW2 or both are non-inferior to CONV in measuring plaque
components and equivalent or more accurate than CONV relative to histology. Aim 1 will
determine whether NEW1 or NEW2 is more repeatable, Aim 2 will determine whether
either or both are non-inferior to CONV in plaque component determination, and Aim 3
will determine the relative accuracy of the three methods, NEW1, NEW2, and CONV
compared with histology. This research will provide a rapid and reliable quantitative
approach for a comprehensive carotid artery exam. This will benefit veterans at risk for
stroke but presently under-treated because the diameter narrowing does not meet
criteria for intervention. It will spare others with stenotic but stable plaque the risk of
surgery. After demonstrating this method can automatically identify plaque features
without expert oversight at the 5 academic VAMCs, this technique will be directly
applicable in the community hospital setting. Although the technology has been
developed on a single vendor’s MRI platform, the NSS coils and related pulse
sequences developed will be transferrable to any MRI scanner hardware and applicable
to imaging other vascular territories and nonvascular tissue. This rapid non-contrast MRI
protocol will fundamentally change the clinical management of cerebrovascular disease.

Public health relevance
MRI, through improved depiction of plaque features, can significantly improve determination of stroke risk compared with carotid stenosis measurements. This proposal will address the limitations to widespread MRI implementation including the need for gadolinium contrast agents, long exam time and steep learning curve required to interpret multi-contrast MRI. Our 5 expert centers will develop a novel MRI method for non-contrast quantitative carotid imaging that will rapidly, automatically and accurately identify vulnerable plaque components. The MRI software and hardware techniques developed will be transferable to other MRI platforms and applicable to imaging other vascular territories and nonvascular tissue. This novel non-contrast MRI protocol should fundamentally change the clinical management of cerebrovascular disease.